Objective tests utilizing Vibrational Spectroscopy for Diagnosis and Severity of Fibromyalgia and Related Pain Syndromes

Central sensitivity syndromes (CSS), including Fibromyalgia (FM), are common and difficult to treat disorders.
The diagnosis of FM depends on the presence of chronic widespread pain along with concurrent central
sensitivity symptoms and absence of an alternative diagnosis. The gold standard for identification of this
neurologic disorder is positive affirmation of diagnosis by a rheumatologist. FM makes up a high percentage of
chronic non-malignant pain conditions which are a major burden on U.S. health care resources. In large chronic
pain cohorts, over 40% meet ACR criteria for FM. Thus, individuals affected with FM and other CSS make up a
substantial proportion of the population receiving opioids. Accurate identification of subjects with FM and other
CSS is urgently needed in order to avoid inappropriate administration of opioids and the danger of chronic opioid
treatment in at risk populations. Our proposal is innovative in both its theoretical underpinnings and
methodological approach of examining spectroscopic analyses as a diagnostic adjunct in well characterized FM
patients while utilizing both subjective and objective monitoring. These proposed studies can lead to evidence
based alternative therapy for this population. The scientific premise is based on the knowledge that non-targeted
fingerprinting approaches have been shown to have a role in identifying FM patients relative to other conditions
including Rheumatoid Arthritis (RA), Osteoarthritis (OA), Systemic Lupus Erythematosus and normal controls
(NC). We now seek to determine the extent to which vibrational (infrared and Raman) spectroscopy technology
and supervised pattern recognition analysis (“chemometrics”) can be honed to further differentiate FM subsets
and pair this approach with complementary metabolomics by LC-MS/MS to identify pharmacologic targets of
interest for this condition that suffers from a lack of reliable therapeutic options. During the R61 Phase we will
(Aim 1): Determine the clinical reliability of bloodspot-based biomarkers to differentiate subjects with FM from
individuals with OA, CLBP (Chronic Low Back Pain), RA, SLE and NCs by vibrational spectroscopy techniques.
We will use multiple validated assessment instruments to grade disease severity. (R61 Aim 2): Determine the
robustness of bloodspot-based biomarker. (R61 Aim 2b): Investigate the effect of intra- and inter-assay
variability, and storage conditions on biomarker reliability using known independent (not used in developing the
calibration model) data sets of subjects from all groups. (R61 Aim 3): Evaluate the metabolic profile of the
biological samples from our subjects. Chemometric analysis of the unique spectral patterns permits
determination of bands most responsible for differentiating test subjects. During the R33 Phase: (Aim 4):
Distinguish FM activity (flares) relative to quiescent phases of FM. Determine changes in disease activity in
patients between baseline and subsequent follow up visits of each patient. The culmination of these aims will
clarify the diagnosis of FM, the most frequent neuropathic disorder encountered in clinical medicine, will help
alleviate unnecessary medical testing and will serve as a deterrent to opioid prescribing in this at risk population.

Public health relevance
Fibromyalgia (FM) is a chronic non-malignant pain disorder that results from abnormalities in central pain processing and accounts for a major percentage of opioid prescriptions thus contributing to the opioid epidemic. An objective marker identifying FM could confirm the presence of disease and mitigate opiate prescribing for this condition that does not respond to them. We will evaluate the potential of vibrational (infrared and Raman) spectroscopy technology and supervised pattern recognition analysis (“chemometrics”) coupled with complementary metabolomics analyses by LC-MS/MS to differentiate FM subjects from other conditions and identify potential pharmacologic targets of interest for this condition that suffers from a lack of reliable therapeutic options.